Point and Listen: Augmented Reality Interfaces for the Visually Impaired

Point and Listen: Augmented Reality Interfaces for the Visually
Impaired
Summary
CamIO (“Camera Input-Output”) is a project designed to make physical objects, including documents,
maps and 3D objects such as architectural models, fully accessible to people who are blind or visually
impaired. It makes these objects accessible by means of an audio-based Augmented Reality (AR)
interface: the user points to a specific location on an object of interest and hears audio information
about this location read aloud (or sees an enhanced image of the selected location if the user has low
vision). Compared with other approaches to making objects accessible to people who are blind or
visually impaired, CamIO offers several advantages: (a) there is no need to modify or augment existing
objects (e.g., with braille labels or special touch-sensitive buttons), requiring only a smartphone and
optional wearable camera device; (b) CamIO is accessible even to those who are not fluent braille
readers; and (c) it permits natural exploration of the object with all fingers to enable audio-haptic
interactions with the object.
Building on our past work on the prototype CamIO iPhone app, we plan to develop powerful
enhancements and new functionality, including finger tracking as an alternative to the use of a pointing
stylus, and support for wearable options such as the camera-enabled Envision Glasses that will offer a
far superior user interface to what is possible with a stand-alone smartphone app. New authoring
capabilities will make it easy for blind and visually impaired users and sighted assistants to create audio
labels for objects. We will also pursue two exciting applications of CamIO in depth: using CamIO to
make tactile maps fully interactive and easier to understand, and the development of interactive
installations such as a 3D scale model of a large playground that helps visually impaired playground
visitors familiarize themselves with the playground’s layout and features. Finally, people who are blind
or visually impaired – the target users of the CamIO system – will be involved in all aspects of the
proposed research, to maximize the impact of the research effort.

Public health relevance
Health Relevance For people who are blind or visually impaired, a serious barrier to employment, economic self- sufficiency and independence is insufficient access to a wide range of everyday objects needed for daily activities that require visual inspection on the part of the user. Such objects include printed documents, maps, infographics, appliances and 3D models used in science, technology, engineering, and mathematics (STEM), and are abundant in schools, the home and the workplace. The proposed research would result in a powerful camera-based smartphone app to provide increased access to such objects for the approximately 10 million Americans with significant vision impairments or blindness.